NIDA DEVELOPMENTAL STUDIES BIOREPOSITORY AND ANALYSIS CENTER. SEPTEMBER 17, 2023 - SEPTEMBER 16, 2024. N01DA-21-5588 TASK ORDER 75N95023F00001 (TO3).

"The NIH Developmental Studies Biorepository
(Non-HEAL HBCD Biorespository portion) "
"The NIH Developmental Studies Biorepository
(ABCD Biorespository)"